Boston University Medical Campus- Massachusetts General Hospital Global Psychiatric Clinical Research Training Program

PROJECT ABSTRACT
The objective of the Boston University Medical Campus-Massachusetts General Hospital Global Psychiatry
Clinical Research Training Program (BUMC-MGH GPCRTP) is to develop independent clinical scientists who
can address the most pressing global mental health challenges. Postdoctoral fellows will be prepared to work
collaboratively across disciplines and cultures in order to respond to the substantial burden of mental health
related diseases in low- to middle-income countries and resource-limited areas, and to develop strategies that
advance global delivery and scale-up of mental health services, improve general wellbeing, and foster overall
country development. The proposed postdoctoral fellowship is a three-year clinical research training program
that will be administered by Boston Medical Center (BMC) and combines rigorous didactic instruction, clinical
research methods training from Boston University and Harvard University, practice in working effectively with
disadvantaged communities, and immersive, mentored clinical research experiences in global settings. Four
fellows will be drawn from a deep pool of talent and will be mentored by a diverse group of faculty who are
recognized leaders in major psychiatric subspecialties as well as clinical research approaches. Each fellow will
have at least one senior mentor at their primary training site (BUMC or MGH), an onsite mentor at the
international site, and an additional mentor specializing in research methods depending on individual needs
and experience. Fellows will complete a mentored research project at an international training site in Barbados,
Ethiopia, Peru, South Africa, Uganda or Ukraine on topics such as addictions, mood disorders, psychotic
disorders, PTSD/trauma/complex emergency, HIV mental health, women’s mental health, and childhood
mental disorders. They will utilize a variety of research skills and techniques to understand the scope of a
problem, and to develop innovative interventions that are feasible and culturally and clinically relevant to the
specific environments and populations. Fellows are expected to be well situated for a NIH or equivalent K
award application by the end of the third year of the program. With heavily circumscribed clinical
responsibilities, trainees will focus on the refinement of their research projects, developing international
collaborations, and strengthening their clinical research skills.

Public health relevance
PROJECT NARRATIVE The objective of the Boston University Medical Campus-Massachusetts General Hospital Global Psychiatric Clinical Research Training Program (BUMC-MGH GPCRTP) is to develop independent clinical scientists who can address the most pressing global mental health challenges. The postdoctoral fellowship is a three-year clinical research training program that combines rigorous didactic instruction, clinical research methods training from Boston University and Harvard University, practice in working effectively with disadvantaged communities, and immersive, mentored research experiences in Barbados, Ethiopia, Peru, South Africa, Uganda and/or Ukraine.